Neuroendocrine regulation of the reproductive axis during puberty and development

DESCRIPTION (provided by applicant): In mammals, including humans, puberty onset reflects the activation of the neuroendocrine reproductive axis, and adolescence is therefore a time of key physiological, anatomical, behavioral, and psychological changes. However, the specific processes timing and governing the activation of the reproductive axis during pubertal maturation and earlier developmental stages remain poorly understood, as does the reason for earlier sexual maturation in girls than boys. Similarly, the reason for a higher incidence of precocious puberty in girls and delayed puberty in boys is unclear. Recently, the neuropeptide kisspeptin, and its receptor Kiss1R, have been implicated in pubertal development and adulthood fertility. Encoded by the Kiss1 gene, kisspeptin stimulates GnRH secretion in mammals, including humans, and mutations in Kiss1 or Kiss1R impair fertility and puberty in rodents and humans. Despite evidence linking hypothalamic Kiss1 neurons to the control of reproduction in adulthood, less attention has recently been given to the role of Kiss1 neurons prior to adulthood. The overall goal of this proposal is to investigate the role of the Kiss1 system in the sex-specific regulation the reproductive axis in postnatal and pubertal development. Aim I will investigate the importance of kisspeptin signaling in the secretion of gonadal steroids during the postnatal critical period, a process which directs sexual differentiation of the brain. Experiments in this aim will assess whether postnatal gonadal steroid secretion is impaired in mice lacking kisspeptin signaling, if kisspeptin treatment can induce gonadal steroid secretion in postnatal females, and whether Kiss1 neurons in specific brain nuclei are activated during postnatal gonadal steroid secretion. Aim II will explore the role of the Kiss1 system in key stages of pubertal maturation. Experiments in this aim will determine when and where (in the brain) Kiss1 neurons first become activated during peripubertal development, whether changes in Kiss1R comprise a key element of pubertal development, and whether acute, short-term blockade of central or peripheral kisspeptin signaling impairs puberty onset. Aim III will investigate the role of both gonadal hormones and non-gonadal factors in regulating Kiss1 neurons during peripubertal development. Experiments in this aim will analyze whether pubertal changes in hormone sensitivity of the reproductive axis reflect developmental changes in the sensitivity of Kiss1 neurons to hormone feedback, assess the timing of developmental changes in gonadal hormone-independent regulation of Kiss1 neurons in relation to puberty onset, and elucidate whether sex differences in peripubertal Kiss1 neurons are organized by hormones during early postnatal life. Overall, this proposal will provide a better understanding of how and when the reproductive axis is regulated during different critical stages of development, as well as where in the brain such regulation is specifically derived. This information could provide important insight into the mechanisms underlying hypogonadotropic hypogonadism, precious puberty, and delayed puberty.

Public health relevance
PUBLIC HEALTH RELEVANCE: Adolescence is a time of critical physiological, behavioral, and psychological changes, but the precise molecular, cellular, and neural mechanisms underlying the regulation of pubertal development remain one of the enigmas of modern science. This proposal investigates the role of hormones and kisspeptin signaling in the regulation of the reproductive axis during key periods of development, including the postnatal "critical period" and sexual maturation (puberty). This work will contribute to our understanding of the critical role of hormones and neural circuits in essential reproductive and developmental processes, and will provide further insight into the mechanisms responsible for various human reproductive disorders and diseases, such as idiopathic hypogonadotropic hypogonadism, nutritional infertility, oligomenorrhea, polycystic ovarian syndrome, and precocious or delayed puberty. PROJECT NARRATIVE Adolescence is a time of critical physiological, behavioral, and psychological changes, but the precise molecular, cellular, and neural mechanisms underlying the regulation of pubertal development remain one of the enigmas of modern science. This proposal investigates the role of hormones and kisspeptin signaling in the regulation of the reproductive axis during key periods of development, including the postnatal "critical period" and sexual maturation (puberty). This work will contribute to our understanding of the critical role of hormones and neural circuits in essential reproductive and developmental processes, and will provide further insight into the mechanisms responsible for various human reproductive disorders and diseases, such as idiopathic hypogonadotropic hypogonadism, nutritional infertility, oligomenorrhea, polycystic ovarian syndrome, and precocious or delayed puberty. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The brain regulates reproduction via gonadotropin-releasing hormone (GnRH) neurons, which stimulate pituitary secretion of luteinizing hormone (LH) and follicle-stimulating hormone (FSH). GnRH neurons are themselves regulated by neural circuits that relay information about circulating hormone levels, metabolic status, and circadian cues, but the mechanisms underlying this are not well known, especially before adulthood. In particular, the processes timing and governing the activation of the reproductive axis during critical periods of postnatal and pubertal development are poorly understood. Recently, the neuropeptide kisspeptin, encoded by the Kiss1 gene, was linked to puberty onset and fertility in mammals, including humans. In adulthood, kisspeptin is synthesized in discrete hypothalamic sites, potently stimulates GnRH secretion, and is directly regulated by gonadal steroids. However, the regulation and function of the Kiss1 system before adulthood is not well elucidated. Specifically, the role of Kiss1 neurons in regulating the hormonal mechanisms that govern postnatal sexual differentiation is virtually unexplored, and the development and function of the Kiss1 system during precise stages of pubertal maturation is poorly characterized. The overall goal of this proposal is to investigate the critical role of the Kiss1 system in regulating the reproductive axis in postnatal and pubertal development in mice. There are 3 Specific Aims: Aim I: Evaluate the role of kisspeptin signaling during the postnatal critical period. Sex differences in the brain and behavior are typically organized in development by the sex-specific secretion of gonadal steroids during the postnatal "critical period". I recently determined that proper sexual differentiation is impaired in transgenic mice lacking the kisspeptin receptor, suggesting that kisspeptin signaling promotes gonadal steroid secretion during postnatal life, as it does in adulthood. However, this conjecture has not yet been tested. It also remains unknown exactly where in the brain (or periphery) kisspeptin signaling may be required for postnatal secretion of gonadal steroids, as well as if the sex-specific pattern of postnatal hormone secretion reflects underlying sex differences in kisspeptin signaling. Experiments in Specific Aim I will examine these issues by assessing 1) whether postnatal gonadal steroid secretion is impaired in transgenic mice lacking kisspeptin signaling, 2) if kisspeptin treatment can induce gonadal steroid secretion in postnatal females (which, unlike males, do not normally secrete gonadal hormones), and 3) whether Kiss1 neurons are activated (i.e., cfos induction) at the time of postnatal gonadal steroid secretion, and if so, in which specific brain nuclei. Aim II: Determine the precise developmental pattern and function of the Kiss1 system during pubertal maturation. Puberty reflects the activation of the neuroendocrine reproductive axis, but the neural and molecular processes underlying this event remain a mystery. Kisspeptin has recently been implicated in puberty onset, supported in part by the fact that adults have higher neural Kiss1 expression than juveniles. However, the precise role of the Kiss1 system in sexual maturation is still poorly understood, and several important questions remain, especially with respect to the timing and regulation of Kiss1 neuron development. When are Kiss1 neurons first activated in relation to pubertal development (before, during, after), and in which specific brain region(s) do pubertal changes in Kiss1 neurons occur? Do changes in Kiss1 expression and neuronal activation occur gradually or abruptly during puberty? In addition to changes in Kiss1 neurons, does puberty also include critical changes in expression of the kisspeptin receptor, either in GnRH neurons or other discrete nuclei? Experiments in Specific Aim II will address these questions by determining 1) the specific developmental pattern and neuroanatomical location of Kiss1 neuron activation during peripubertal development, 2) whether changes in kisspeptin receptor levels in GnRH cells are involved in pubertal development, and 3) whether acute, short-term blockade of either central or peripheral kisspeptin signaling during key times impairs puberty onset. Aim III: Analyze the regulation of Kiss1 neurons by gonadal and non-gonadal factors during peripubertal development. Regulation of the reproductive axis during peripubertal development involves a complex mix of both gonadal hormone-dependent and gonadal hormone-independent mechanisms. In rodents, one key event during puberty is a decrease in the sensitivity of reproductive neural circuits to gonadal steroid negative feedback. However, the specific neural location, and underlying mechanism, of this pubertal change in gonadal steroid sensitivity remains a mystery. Kiss1 neurons, which are directly regulated by gonadal steroids in adulthood, may be the specific neuronal substrate where sensitivity to gonadal steroids changes during puberty. In addition, Kiss1 neurons in prepubertal mice are also regulated by gonadal hormone-independent factors, but only in males. This intriguing sex difference in the regulation of developing Kiss1 neurons may relate to sex differences in the timing of puberty onset, which occurs later in males than females (including humans). However, the specific timing of developmental changes in gonadal hormone-independent regulation of reproductive circuits remains unknown, as does the developmental mechanism underlying the sexual differentiation of the regulation of prepubertal Kiss1 neurons. Specific Aim III will study how and when gonadal and non-gonadal factors regulate Kiss1 neurons during peripubertal development by determining 1) whether pubertal decreases in gonadal hormone sensitivity reflect changes in gonadal steroid responsiveness of Kiss1 neurons, 2) when in development gonadal hormone-independent regulation of Kiss1 neurons is first lifted in each sex relative to puberty onset, and 3) whether the sex difference in hormone- independent regulation of prepubertal Kiss1 neurons is organized at birth by postnatal sex steroid signaling. Overall, this proposal seeks to elucidate the role of neural kisspeptin signaling in the regulation of the reproductive axis during key periods of development, including the postnatal critical period and pubertal maturation. Despite extensive research, the precise mechanisms underlying the regulation of the reproductive axis during these developmental periods have remained elusive. Kiss1 neurons, stimulating GnRH secretion through the activation of the kisspeptin receptor, could be essential factors governing the reproductive axis during critical developmental ages. In addressing this possibility, this proposal will provide a better understanding of how and when the reproductive axis is regulated during different stages of development, including adolescence, as well as where in the brain (or periphery) such regulation is derived.